IDeA Entrepreneurship Training and Community Development

Summary
Scientists are motivated by the notion that their work could improve or save lives; however, moving medical
innovations from bench to bedside is challenging. Biomedical entrepreneurship can be a career choice but is
also key to translating these investments in medical research by the commercialization of innovative ideas.
To succeed at this translation, a whole new set of skills are required, such as; understanding the barriers to
adoption in the complex healthcare market, business plan development, regulatory requirements, securing
the financial resources, and protection of intellectual property. Training in biomedical entrepreneurship is
limited in the Institutional Development Award program (IDeA)-eligible states. We posit that innovative
training opportunities that close this foundational knowledge and skills gap will speed the commercialization
of biomedical inventions and career progression. To address this need and education gap we established the
IDeA-Entrepreneurship (I-Trep) training program. The overall goal of I-Trep is to promote
entrepreneurship in biomedical research and to jump start and facilitate the transition of innovative
ideas and discoveries from the laboratory or bedside into the marketplace. To date, we have engaged
seven target states (VT, NH, ME, RI, DE, AK and Puerto Rico) and moved careers forward. We have trained
or assisted a highly diverse group of scientists, who have raised to date $8 million in SBIR/STTR grant dollars
and two I-Trep -assisted companies have now raised $20 million from private investors. I-Trep is being
revamped with a next phase of development, innovation, and expansion to create an IDeA entrepreneurial
ecosystem. We will now move forward to engage the entire IDeA program of 23 states plus Puerto Rico with
the aims and goals for the next phase that are: 1) Promote early career training in biomedical
entrepreneurship through innovative training opportunities. This will be achieved using innovative
principles of active learning, we will deploy virtual and asynchronous learning opportunities, an I-Trep Studio
program, and an I-Trep Fellows program. 2) Build a virtual community of practice. Mentoring of early-
stage entrepreneurs will be achieved through the establishment of an online community of practice
(ecosystem)- allowing members to a) connect with peer mentors, b) received one-on-one mentoring from
vetted consultants, c) find internship opportunities to gain practical experience. and 3) Marketing. We will
disseminate our training program by using a multifaceted approach that is grounded in best practices and
innovations in communications and build the community of practice in collaboration with several NIGMS
Regional Technology Transfer Hubs. I-Trep fills a unique niche through the education and training of
academic scientists so that they can interact more effectively with business professionals and thus realize the
successful translation of scientific discoveries to market.

Public health relevance
Narrative Entrepreneurship is a complex series of activities that are both dynamic and very context dependent, critical to the successful translational of biomedical research discoveries; yet, entrepreneurial skills training is all but absent from traditional biomedical educational curricula. The Institutional Development Award IDeA- Entrepreneurship (I-Trep) training program is designed to provide a suite of opportunities that will moved the careers of a diverse group of young scientists forward. Biomedical entrepreneurship can be a career choice but it is also key to the commercialization of innovative ideas derived from investments in medical research with the goal to improve patient's lives.